Locus coeruleus regulation of hippocampal network reset during learning

Project Summary
Attention and memory systems closely interact to ensure we encode the things that matter. A growing body of
research implicates noradrenergic signaling from the locus coeruleus (LC) to the hippocampus in organizing
episodic memories around moments of transition, when arousal is heightened and the focus of attention shifts.
These transitions often occur when memory-guided predictions deviate from reality, either due to changes in the
external environment, or when mental models fail to capture the key elements of an experience that should guide
behavior. Across the brain, norepinephrine (NE) is thought to assist in cognitive flexibility by resetting which
neural networks are active before and after a prediction error. It is unknown whether hippocampal output
networks can drive NE release. Moreover, how NE contributes to neural coding in hippocampal networks at the
time of learning is also poorly understood. Our central thesis is that the hippocampal output region CA1 controls
NE release from the LC to facilitate behavioral flexibility through hippocampal network reset. This working model
will be tested in three Specific Aims (SAs) that employ electrophysiology, fluorescent imaging of NE binding, and
optogenetics in the awake behaving mouse. In SA1, we will examine LC control of hippocampal reset, or
remapping, in the context of unexpected changes in external stimuli. In SA2, we will study whether CA1 network
reset facilitates spontaneous shifts in behavioral strategy. SA3 will directly test whether hippocampal output
networks drive NE release during reset. We hypothesize that, in each case, LC activity promotes remapping
dynamics at the time of potential network reset. This proposal will test whether a common, NE-mediated process
may segment episodic memory around transition points driven by unexpected changes in external stimuli (SA1),
internally-driven changes in which policy drives behavior (SA2), or by a surprise signal directly generated in CA1
(SA3). The goal of this proposal is to establish a causal role of the hippocampal-LC loop in fostering behavioral
flexibility by facilitating transitions between the hippocampal representations of remembered, or to-be-
remembered, experiences. Psychiatric symptoms across a broad range of disorders have been linked to parallel
deficits in memory formation and attentional control. The foundational understanding expected from our planned
studies will ground conceptual and computational models of how cognitive problems arise due to maladaptive
interactions between the systems that control attention and those that are involved in making long-term
memories.

Public health relevance
Project Narrative Attention and memory systems closely interact to ensure we encode the things that matter. In this proposal, we will test whether the brain systems that control attention and arousal affect memory centers by driving changes in neural activity when the focus of attention shifts, a process that is essential for cognitive and behavioral flexibility. By studying the gate that controls transitions between neural representations, we hope to provide a new lens through which to understand the comorbid attention and memory deficits seen across psychiatric and neurological conditions.